CD138 Regulates Competition of Antibody Secreting Cells for Survival

Long-lived antibody secreting cells (LLASCs) are critical immune effector cells constitutively
secreting high affinity antibody providing prophylaxis against infections. In contrast to live
attenuated viruses which can provide lifelong immunity, protein-based vaccines are known to
poorly induce LLASCs, often requiring multiple boosting to generate sufficient antibody titer. The
factors that control LLASC production are poorly understood, but are critically important for all
humoral-based vaccines. Survival of LLASCs is chiefly mediated by soluble cytokines, such as
APRIL in the BM, and IL-6 in secondary lymphoid tissues. After immunization, antibody
secreting cells (ASCs) express variable levels of CD138, and its function was unclear, since it
can bind 100+ proteins, and CD138-/- have no overt phenotype. However, we have recently
published a study that finally details a direct role for CD138 for potent antibody responses, by
controlling ASC maturation and survival after immunization. LLASCs express the highest level
of CD138 among all cells, in comparison to newly minted ASCs, which express intermediate
levels of CD138. We proposed that high expression of CD138 provides LLASCs with higher
binding and accumulation of IL-6 and APRIL, which are limiting, leading to a competitive
advantage over new ASCs for survival. In Aim 1, we will test this competition model in this
grant, which can explain poor vaccine responses as well as how LLASCs are maintained over
time and repeated immune responses. In Aim 2 we will explore ways to increase CD138 after
vaccination to enhance ASC survival and long term immunity. In Aims 3 & 4, we will explore
CD138 function in pathological conditions.

Public health relevance
Antibody secreting cells (APCs) are most responsible for antibody production after vaccination or infection. A population of long-lived ASCs can be found in the bone marrow and can survive a lifetime making antibody. This proposal is addressing how to increase the production of these cells to improve vaccine efficacy.